Lysosomal Disease Network Administrative Core

The Lysosomal Disease Network Administrative Core will function as the central unit of the consortium,
providing the organizational and functional structure that will keep the consortia moving toward achieving the
research goals stated in this application. The Core will be the point of contact for the External Advisory
Committee, manage announcements related to Pilot/Feasibility projects and Career Enhancement
opportunities, and maintain the consortium website (www.lysosomaldiseasenetwork.org). The Core
Administrative Coordinator will be the point person for all central IRB activities across the network and assume
responsibility for clinicaltrials.gov postings. The Core also serves as the organizing entity for the LDN affiliated
Patient Advocacy Groups and other primary stakeholders, including study participants.
Financial oversight of the network is managed by the Core, including routine review of study outcomes and
goals.